Summer Undergraduate Research Program in Neuroscience of Addiction

PROJECT SUMMARY/ABSTRACT
This renewal application seeks support for our well-established research education program in substance use
disorders to support undergraduate students pursuing short-term summer research experiences at the Medical
University of South Carolina (MUSC). The goal is to develop the next generation of independent researchers
who can progressively enhance existing therapies and develop novel approaches to substance use disorders.
The specific aims are to: 1) Foster interest in these talented and highly motivated students to pursue careers in
biomedical research in the areas of addiction research by providing a forum where accomplished investigators
can be mentors sharing their enthusiasm and expertise; 2) Leverage existing research training programs at
MUSC to complement and expand the overall experience of the students; 3) Provide a forum where students
not only acquire the basics of how to address research problems, but also learn cutting edge research
techniques, research ethics, and presentation of research data; 4) Contribute to enhancing the students' overall
science literacy by nurturing an appreciation of the nature of science and acquisition of socioscientific skills and
values.; and 5) Implement a comprehensive evaluation plan that measures the degree to which the program is
achieving its objectives. Each year, fourteen undergraduate students will have the opportunity to conduct
biomedical research projects under the guidance of faculty mentors based primarily in the Department of
Neuroscience. The ten-week summer research projects conducted by the students will culminate in a formal
scientific presentation. Additional activities include a lecture series on focused topics; a research ethics
component; formal and informal discussions on the meaning of scientific literacy, professional development and
career opportunities; and social functions. The participating faculty constitutes a highly collaborative,
interdisciplinary team of laboratory-based researchers. Training opportunities are thematically organized around
four areas of research: neurobiological basis of cocaine relapse; neurobiology of methamphetamine
dependence; sex and gender related research in substance use disorders; and stress and substance use
disorders. The program builds upon and leverages (1) MUSC's strong and continued commitment to research
training; (2) its excellent reputation in providing meaningful research experiences for talented undergraduate
students; (3) its record of accomplishment of attracting students from underrepresented groups and
undergraduate institutions, and (4) its effective program management. This R25 program will teach and promote
the integration of clinical and basic science knowledge, with an emphasis on acquiring research skills in the basic
neurobiology of substance use.

Public health relevance
PROJECT NARRATIVE The goal of this program is to attract talented undergraduate students into careers in the biomedical sciences, particularly in fields relevant to the mission of the National Institute of Drug Abuse. This is expected to increase the supply of qualified investigators who are studying substance use disorders, as well as contribute to overall science literacy by equipping students with appropriate science skills and an appreciation for biomedical research.